Development of O’PROTACs-based degraders targeting an oncogenic viral protein

Kaposi’s Sarcoma-associated Herpesvirus (KSHV) is the etiologic agent of several human cancers, including
Kaposi’s Sarcoma (KS) and Primary Effusion Lymphoma (PEL), which preferentially arise in
immunocompromised patients (e.g., HIV+ personnel or organ transplant recipients) and lack of effective
therapeutic options. Despite the reduced incidence of KS in the era of combined Antiretroviral Therapy (cART)
for HIV infection, KS still remains one of the most common AIDS-associated tumors and a leading cause of
morbidity and mortality in this setting. PEL is a rapidly progressing malignancy with a median survival time of
approximately 6 months, even under the combinational chemotherapy. Therefore, KSHV-induced malignancies
still represent a serious threat to immunosuppressed patients due to the lack of effective therapies. This project
aims to design and develop O’PROTAC-based degraders which specifically targeting LANA expression, a
KSHV-encoded major oncoprotein, to interfere with the survival of KSHV+ tumor cells in vitro and in vivo. We
hope we can develop new interventional strategies through targeting oncogenic virus itself for improving the
outcome of these virus-associated malignancies in high-risk immunocompromised patients.

Public health relevance
Tumors etiologically linked to the Kaposi's sarcoma-associated herpesvirus (KSHV/HHV-8), including Kaposi’s sarcoma (KS) and Primary effusion lymphoma (PEL), are preferentially arising in immunocompromised patients but lacking of effective therapy. The current project aims to develop a new strategy directly targeting major viral oncogenic protein against these virus-associated malignancies.